PROMACE-CYTABOM TREATMENT FOR ANGIOCENTRIC IMMUNOPROLIFERATIVE LESIONS

This protocol was designed to improve the prognosis of patients with all grades of angiocentric immunoproliferative lesions. Seven patients have been entered on study. All seven patients have achieved a complete response and 2 have relapsed. Both relapsed patients have undergone bone marrow transplantation and remain in their second complete remission for 2+ and 1+ years. No patient has died. More patients and longer follow-up are necessary to draw any conclusions.